Novel alveolar mechanisms of hypoxemia in hepatopulmonary syndrome

Project Summary & Abstract
Cirrhosis afflicts more than 4.5 million Americans and hepatopulmonary syndrome (HPS), the most common
pulmonary complication of cirrhosis, occurs in up to 30% of patients and significantly increases mortality. No
effective therapies exist due to our incomplete understanding of cellular mechanisms. Although classically
recognized as alveolar microvascular remodeling causing hypoxemia, the poor correlation between hypoxemia,
the degree of microvascular changes, and outcomes in HPS remain unexplained. To address this knowledge
gap, we have identified novel abnormalities in the alveolus itself in experimental HPS, along with restrictive
ventilatory defects and elevated circulating bile acids in human disease. Our hypothesis is that elevated
circulating bile acid levels in cirrhosis, affect alveolar epithelial type 2 cells (AT2 cells), leading to impaired
surfactant production and restrictive ventilatory defects which influence the progression and outcome of HPS.
To elucidate the role of bile acids and AT2 cells in HPS, we propose to 1) assess the correlation between bile
acid levels and the presence and severity of HPS 2) define the role of AT2 cells in HPS and 3) determine the
mechanisms and consequences of bile acid medicated AT2 cell loss. Completion of this work will define the
mechanisms and significance of AT2 cell dysfunction in HPS, identify novel therapeutic targets and form the
foundation for a broader understanding of how chronic liver disease influences lung function.

Public health relevance
Project Narrative Hepatopulmonary syndrome (HPS), the most common lung complication in cirrhosis, results in impaired transfer of oxygen into the blood, increases the risk of dying and has no effective medical treatments. The current proposal focuses on the novel hypothesis that bile acids, increased in cirrhosis, impair the function of the lung surfactant system and contribute to decreased oxygen and poor outcomes. Our goal is to develop effective treatments for HPS.